Reproductive and Developmental Toxicity of Dioxin

DESCRIPTION (provided by applicant): The long-range goal is to understand how aryl hydrocarbon receptor (AHR) signaling pathway activation affects prostate development and prostate disease. The developing prostate is highly sensitive to 2,3,7,8-tetra-chlorodibenzo-p-dioxin (TCDD), the prototypical AHR agonist. In mice, TCDD inhibits prostatic bud formation by the fetal urogenital sinus (UGS), prevents the ventral prostate lobe from forming, and permanently alters the structure and function of the other prostate lobes. Preliminary results show that β-catenin is essential for normal prostate development and implicate aberrant β-catenin signaling as the key mechanism by which TCDD causes prostate abnormalities. Hypotheses to be tested in wild-type and transgenic C57BL/6J mice are as follows: Aim 1: TCDD inhibits prostatic bud formation by decreasing β-catenin signaling in basal urogenital sinus epithelium (UGE). Aim 2: TCDD down-regulates β-catenin signaling by decreasing expression of canonical Wnts and Rspos, and/or by increasing expression of non-canonical Wnts, in urogenital sinus mesenchyme (UGM). Aim 3a-c: TCDD epigenetically alters gene expression in the fetal UGE, and does so via β-catenin down-regulation; Aim 3d: In utero and lactational TCDD exposure causes the senescent prostate to retain the epigenetic signature seen in TCDD-exposed fetal UGE and to inappropriately retain androgen responsiveness characteristic of young control adults. Aim 4: In utero and lactational TCDD exposure accelerates prostate adenocarcinoma progression in Nkx3.1; Pten mice and TCDD treatment in adulthood does likewise. Results from Aims 1 and 2 will significantly advance our understanding of the mechanisms by which AHR agonists affect early prostate development, and may help explain how TCDD and related chemicals cause abnormal development of other organs that also develop via mesenchyme-induced epithelial budding and branching (e.g., breast and lung). As for long-term effects, it has already been established that in utero and lactational TCDD exposure causes the dorsolateral prostate to retain abnormally high androgen dependence into senescence, and increase susceptibility to a type of prostate tumor (neuroendocrine) that is uncommon in men. Aims 3 and 4 will in part determine if low-level maternal TCDD treatment also increases (a) androgen responsiveness in the senescent dorsolateral prostate, and (b) susceptibility to prostate adenocarcinomas, the most common prostate tumor type in men. Aim 4 will also determine if Nkx3.1; Pten mice are an appropriate model for studying the increase in prostate cancer seen in Vietnam veterans exposed to the TCDD-contaminated herbicide Agent Orange. The proposed research has a high likelihood of establishing that β-catenin signaling abnormalities are key contributors to TCDD toxicity in mammals, and of establishing that fetal TCDD exposure creates an epigenetic signature in the prostate, one associated in adulthood with altered responses to androgens and with cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE: The developing prostate in lab animals is exceptionally sensitive to the ubiquitous environmental contaminant TCDD; therefore, it is likely that the prostate in humans is also at risk. The proposed research will substantially increase our understanding of how exposure to TCDD and related chemicals early in life permanently changes the prostate and its susceptibility to disease. In addition, it includes the first controlled animal study of whether TCDD exposure in adulthood increases the risk of prostate adenocarcinoma, the most common type of prostate cancer in men. NARRATIVE The developing prostate in lab animals is exceptionally sensitive to the ubiquitous environmental contaminant TCDD; therefore, it is likely that the prostate in humans is also at risk. The proposed research will substantially increase our understanding of how exposure to TCDD and related chemicals early in life permanently changes the prostate and its susceptibility to disease. In addition, it includes the first controlled animal study of whether TCDD exposure in adulthood increases the risk of prostate adenocarcinoma, the most common type of pros- tate cancer in men. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS The long range goal is to understand how activation of aryl hydrocarbon receptor (AHR) signaling affects prostate development and disease. Our preliminary results show that β-catenin is essential for normal prostate development and implicate aberrant β-catenin signaling as the key mechanism by which the prototypical AHR agonist 2,3,7,8-tetrachlorodibenzo-p-dioxin (TCDD) causes prostate abnormalities. The first two aims examine the roles of β-catenin, and of its wingless-related MMTV integration site (WNT) and R-Spondin (RSPO) regulators, as the fetal prostate develops from the urogenital sinus (UGS) of control and TCDD-exposed mice. The third aim examines whether epigenetic modification in fetal urogenital sinus epithelium (UGE) by TCDD is the fetal basis of age-inappropriate prostate androgen responsiveness when exposed males reach old age, and if the epigenetic changes occur via changes in β-catenin signaling. The final aim will determine if consequences of perinatal prostate reprogramming by TCDD include increased prostate adenocarcinoma progression, and if Nkx3.1+/-; Pten+/- mice are an appropriate model for investigating mechanisms by which TCDD increases prostate cancer in men. 1. Determine if TCDD inhibits prostatic bud formation by decreasing β-catenin signaling in basal UGE. Hypotheses to be tested: (a) In utero TCDD exposure decreases β-catenin protein abundance and β-catenin-responsive gene expression in basal UGE cells, (b) Transgenic mice expressing a dominant stable β-catenin in basal UGE cells are protected from prostatic budding inhibition by in utero TCDD exposure, and (c) UGS organ cultures transfected with a β-catenin-responsive gene, Sox9, are protected from inhibition of prostatic bud formation by TCDD. 2. Determine if TCDD decreases β-catenin signaling in basal UGE by decreasing mRNA abundance of canonical Wnts and Rspos and/or by increasing mRNA abundance of non-canonical Wnts in uro- genital sinus mesenchyme (UGM). Hypotheses to be tested: (a) In utero TCDD exposure decreases relative mRNA abundance of canonical Wnts and Rspos and/or increases relative abundance of non-canonical WNTs in peri-prostatic UGM, (b) TCDD-treated UGS organ cultures exposed to increasing concentrations of a canonical WNT (i.e., rWNT3A) or to an inhibitory antibody against a non-canonical WNT (e.g., WNT5A) are protected from reduced β-catenin signaling in basal UGE cells and from inhibited prostatic bud formation, and (c) WNT5A and Foxy-5 treatment of UGS organ cultures phenocopy TCDD by reducing β-catenin signaling in basal UGE cells and by inhibiting prostatic bud formation. 3. Determine if TCDD epigenetically alters gene expression in prostatic progenitor cells in basal UGE, if it does so by down-regulation of β-catenin signaling, and if in utero and lactational TCDD exposure causes the young adult and senescent prostate to retain (a) this epigenetic signature and (b) androgen dependence and responsiveness characteristic of young control adults. Hypotheses to be tested: (a) In utero and lactational TCDD exposure causes DNA methylation to be altered in dorsolateral prostate epithelium of young adult mice, (b) A subset of the genes differentially methylated in young adult dorsolateral prostate by in utero and lactational TCDD exposure (Aim 3a) is also differentially methylated in basal UGE by in utero or in vitro TCDD exposure , (c) A subset of the genes differentially methylated in basal UGE cells by TCDD (Aim 3b) is phenocopied by treatment with non-canonical WNT5A but not by canonical WNT3A, which protects against DNA methylation changes induced by TCDD and WNT5A, and (d) In utero and lactational TCDD exposure causes the dorsolateral prostate epithelium of senescent males to retain the same TCDD epigenetic signature seen in young adulthood, and to inappropriately retain androgen dependence and responsiveness characteristic of young control males. 4. Determine if TCDD accelerates prostate adenocarcinoma progression in Nkx3.1+/-; Pten+/- mice. Hypotheses to be tested: (a) In utero and lactational TCDD exposure accelerates prostate adenocarcinoma progression in Nkx3.1+/-; Pten+/- mice, and the TCDD epigenetic signature identified in Aim 3 is present in adenocarcinomas from these TCDD-exposed mice, and (b) TCDD exposure in adulthood accelerates prostate adenocarcinoma progression in Nkx3.1+/-; Pten+/- mice.